Metabolic Markers and Predictors of Childhood Obesity

PROJECT SUMMARY / ABSTRACT
This project is responding to the Notice “Ancillary reproductive health projects to existing large and/or
longitudinal studies, as an Administrative Supplement to the parent grant R01 HD028016 ‘Metabolic Markers
and Predictors of Childhood Obesity. This project is designed to assess the reproductive health in a large cohort
of women in their 20’s, 30’s, and 40’s who previously underwent metabolic phenotyping as adolescents with
obesity. The goal is to determine the characteristics of early obesity that play a role in future reproductive
pathologies. The study strategy will generate subgroups with deepening biological measures to enable the
breadth of research from epidemiology to the mechanism. First, we will study the cohort of women over 18
using a computer-generated review of their medical records to determine updated contact information and
incidence of reproductive disorders (Subgroup 1). Then we will use this refined cohort to increase the depth of
data by re-contacting and consenting 500 women to complete a questionnaire with details about their
reproductive events and metabolic health (Subgroup 2). From these participants, we will invite 200 women for
a research visit to measure anthropometrics and to donate fasting serum (Subgroup 3). Sub-group 3 will
represent participants in the highest and lowest quartile of either hepatic and visceral fat per the MRI data
obtained when they were adolescents or insulin area under the curve per their first oral glucose tolerance test.
Finally, we will invite even a smaller subgroup of 20 women to donate a piece of endometrium via biopsy
(Subgroup 4). Data and biospecimens will be protected and shared with investigators for hypothesis-driven
research.

Public health relevance
PROJECT NARRATIVE This proposal aims to determine the characteristics of early obesity that play a role in future reproductive disorders. We will invite women in their 20’s, 30’s, and 40’s who previously participated in metabolic studies when they were adolescents to provide information about their menstrual cycle, any difficulties they have becoming pregnant or delivering babies, and diagnosis of pre-cancer and cancer of the endometrium. Women may also donate blood and/or endometrial tissue for future research to understand how weight affects their hormones and uterus.